Increasing racial diversity in scientific hiring through Scismic Job Seeker, an online job-matching platform for the biotech industry

Project Abstract Scismic Job Seeker is a Match.com for scientific hiring. In identifying the need to improve workforce engagement in the life sciences, Scismic built an automated job-­matching platform tailored for the biotech industry. Designed, developed, and now deployed by scientists for scientists, its skills-­matching technology is unique and addresses key evaluation criteria in assessing candidates as required by recruiters. Therefore, Scismic saves biotech companies time and money, and optimizes productivity by enabling scientists to find workplaces they thrive in. Scismic aims to foster engagement and drive innovation in the life sciences industry. Racial diversity, a key contributing factor to organizational productivity and innovation, is severely lacking in the biotech workforce. Past studies have shown that traditional recruiting practices create barriers for candidates of underrepresented backgrounds. As a technology platform with algorithms that compute automated candidate evaluations, Scismic Job Seeker’s matching system reduces human biases in the candidate evaluation process. Additionally, Scismic has developed two new independent diversity-­promoting features, 1) biographical information blinding (BIB) and 2) enhanced written evaluation (EWE). The specific aims of this SBIR Phase I application are 1) to demonstrate the efficacy of Scismic Job Seeker’s BIB feature in generating racially diverse candidate shortlists and 2) to determine the efficacy of Scismic Job Seeker’s EWE in delaying the introduction of human bias in the recruiting process. In the proposed studies, Scismic will 1) determine whether two screening features, the BIB and the EWE, result in more underrepresented candidates being moved forward, 2) understand the correlation between the racial diversity of candidate pools before and after Scismic Job Seeker+BIB-­screens, and 3) establish whether the EWE can replace the phone screen and further delay the introduction of human bias prior to the interview stage. The results of the proposed study will enable Scismic to further optimize and improve the BIB and/or the EWE for integration into the Scismic Job Seeker platform. If one or both of these features demonstrate the ability to generate more diverse candidate selections than those of human recruiters, these feature(s) will be improved and integrated into Job Seeker’s platform for commercialization in the SBIR Phase II application. In addition, biopharmaceutical companies have expressed tremendous interest in piloting Scismic Job Seeker+BIB+EWE alongside their current recruiting practices. By providing the only widely accessible and scalable platform addressing diversity life science recruiting, Scismic Job Seeker can further increase therapeutic innovation in the biotech industry. In the long-­term, Scismic seeks to accelerate research innovations worldwide by enriching the biotech workforce with new perspectives from previously excluded scientists.

Public health relevance
Project Narrative Scismic Job Seeker is an online platform that matches candidates to jobs in the biotech industry to increase workforce engagement and propel scientific innovation. To further accelerate biotech innovation, new diversity- promoting features have been integrated, since diversity has been shown to foster organizational productivity and innovation. Comparative studies assessing candidate selection through Scismic Job Seeker and traditional recruiting practices will inform the entire biotech industry of effective tools to build a more diverse workforce, which in turn will drive scientific innovation and lead to more therapeutics.